BRidging Information Divides and Gaps to Ensure Survivorship: the BRIDGES Randomized Controlled Trial of a Multilevel Intervention to Improve Adherence to Childhood Cancer Survivorship

PROJECT SUMMARY
More than 80% of childhood cancer survivors (CCS) develop serious or life-threatening late effects. Yet <20%
of CCS receive recommended survivorship care, despite the availability of consensus guidelines for lifelong
surveillance for late effects starting 2 years post-therapy. The “gold standard” cancer center-based survivorship
clinic provides high-quality care to CCS who attend, but patients avoid reminders of their past cancer and lack
knowledge and self-efficacy for survivorship care. Other barriers include travel distance, inadequate insurance,
and out-of-pocket costs—these structural issues contribute to health disparities. Partnering with community
primary care provider (PCP) clinics in a shared model of care is a promising strategy to overcome these barriers,
but PCPs lack knowledge, self-efficacy, and interactive communication with the cancer center and are confused
about the division of care responsibilities. Our intervention is scalable and distance-based, is informed directly
by patient and PCP barriers and preferences from previous studies, and is boosted by a nationwide explosion in
telehealth services precipitated by the COVID-19 crisis. The proposed randomized controlled trial will enroll 240
CCS 2.0-4.0 years post-chemotherapy/radiation to investigate an innovative multi-level intervention (i.e.,
interpersonal and organizational levels) consisting of 1) patient survivorship education via telehealth with the
cancer center, 2) ongoing patient-tailored education program within the EHR's patient portal, 3) a structured
interactive phone communication between the cancer center and the PCP clinic (with 1-year follow-up call), and
4) an in-person visit with the PCP clinic for survivorship care. The comparison group will be randomized to an
in-person visit with their cancer center survivorship clinic. This study includes 4 centers with high proportions of
subgroups vulnerable to survivorship care disparities (i.e., rural, Black, Latinx, Spanish-speaking,
socioeconomically disadvantaged). Both groups will be asked to begin recommended surveillance for late effects
within 1-year post-randomization, separate from tumor recurrence monitoring by the primary oncologist. Our
Specific Aims are to Aim 1- Demonstrate patient completion of guideline-recommended surveillance tests in
intervention participants is not inferior, i.e. within 10%, to that in the comparison group; Aim 2- Achieve greater
1) patient knowledge, self-efficacy, and activation and 2) PCP knowledge and self-efficacy with survivorship care
among intervention participants and their PCPs compared to the comparison group; and Aim 3- Ascertain
process outcomes for the 1) patient and 2) PCP clinic. Outcomes will also be assessed among subgroups with
survivorship care disparities. Transformative Impact: If our intervention demonstrates patient completion of
recommended survivorship care comparable to cancer center survivorship clinic, our study has the enormous
potential to deliver recommended lifelong care to a larger proportion of CCS and reduce survivorship care
disparities, while engaging patients and PCPs to integrate survivorship care as part of overall, lifelong health
maintenance.

Public health relevance
Project Narrative More than 80% of childhood cancer survivors develop serious or life-threatening late effects after cancer therapy, but <20% receive recommended survivorship care offered at cancer center survivorship clinics. In a shared care model, we propose to investigate an innovative multi-level intervention consisting of: 1) patient survivorship education via telehealth with the cancer center, 2) ongoing patient-tailored education program within the electronic health record patient portal, 3) a structured interactive phone communication between the cancer center and the primary care clinic, and 4) an in-person visit with the primary care clinic for survivorship care with the goal of achieving high rates of adherence to recommended surveillance for late effects, as well as improving patient and physician knowledge and self-efficacy. If our scalable intervention demonstrates patient completion of recommended care comparable to cancer center survivorship clinics, our innovative study has the enormous potential to deliver recommended care to a larger proportion of childhood cancer survivors and reduce survivorship care disparities, while engaging patients and primary care providers to integrate survivorship care as part of overall, lifelong health maintenance.